Efficacy of digital cognitive behavior therapy for insomnia for the prevention of perinatal depression

PROJECT SUMMARY/ABSTRACT
Approximately 1 in 7 women experience perinatal depression (i.e., during pregnancy or the postpartum period),
making it the most common complication of childbirth. Perinatal depression is associated with long-lasting
consequences, including increased risk of suicide, impairments in parenting, and immense societal costs.
Prenatal insomnia is a robust risk factor for perinatal depression: nearly 1 in 4 women who experience prenatal
insomnia develop postpartum depression. To date, depression prevention interventions mainly focus on
pregnant women with elevated depressive symptoms or a history of depression, and no trials have investigated
whether treating prenatal insomnia prevents perinatal depression. Digital cognitive behavior therapy (CBT-I) is
safe and effective for treating prenatal insomnia and shows promise for preventing perinatal depression
relative to standard care. Further, digital CBT-I may be of particular interest for pregnant women because it
minimizes wait time, avoids burdensome traveling and scheduling requirements, and meets their preferences
for flexible delivery options. The proposed project is a blinded randomized controlled trial to evaluate the
efficacy of digital CBT-I for the prevention of depression during pregnancy and through 12 months postpartum
among 498 non-depressed women with insomnia disorder relative to a credible, clinically-relevant control
condition. Consistent with other research, sleep hygiene education will be the control condition, and will match
digital CBT-I in delivery format (digital), frequency (weekly), and number of sessions (six). The proposed
confirmatory efficacy trial addresses three specific aims: 1) To evaluate the efficacy of digital CBT-I for
preventing perinatal depression; 2) To test whether the effect of digital CBT-I on perinatal depression is
mediated through prenatal insomnia symptom improvement; 3) To test whether the effect of digital CBT-I on
perinatal depression is moderated by baseline depressive symptom severity. By focusing on a low stigma
target (i.e., prenatal insomnia) and using a scalable intervention, this approach has the potential to facilitate
broad dissemination. The proposed project has high public health significance for reducing the burden of
perinatal depression for mothers, families, and society.

Public health relevance
PROJECT NARRATIVE This research will provide definitive evidence about whether treating prenatal insomnia with digital cognitive behavior therapy for insomnia prevents depression during the perinatal period (i.e., pregnancy and the postpartum period). Currently, there are few intervention options for preventing perinatal depression, none focus on women with prenatal insomnia, and the accessibility of existing interventions is limited. Several attributes of our approach will facilitate its broad dissemination, including focusing on the low stigma target of insomnia and using a scalable intervention, with significant public health impact for reducing the burden of perinatal depression for mothers, children, families, and society.